Development of Modular CRISPR Genome Editing Technologies and Tools

Mouse models are essential for virtually every aspect of biomedical research. A recent NIH analysis indicates
that as many as 71% of NIH R01 awards may use mouse models. The Knockout Mouse Project (KOMP) and
the International Knockout Mouse Consortium (IKMC) were successful in generating conditional knockout
(cKO) ES cell clones for nearly 90% of genes; however, only about 25% of these were converted into mice by
2013, the year when CRISPR technologies affected the workflow at KOMP/IKMC centers. Subsequently, very
rapid CRISPR/Cas9-based technologies that bypass ES cells were widely adopted for generating simple KO
mice, but proved difficult for cKO models. To solve this problem, we developed Easi-CRISPR, in which single-
stranded DNA donors with short homology arms substitute for double-stranded DNA donors with long
homology arms. Because Easi-CRISPR is simple, rapid, and efficient, and has proved reproducible at multiple
loci in multiple laboratories, many groups, including KOMP laboratories, have adopted our method. To extend
the success of breakthrough technologies like Easi-CRISPR, we propose to solve much bigger problems that
are universal to projects using mouse models. Some examples of these challenges are; (1) reducing the
excessive amount of time spent in breeding Cre-LoxP models; (2) addressing the limited availability of Cre
driver lines; (3) developing CRISPR-based technologies for knock-out first models, the most elegant and
versatile design used at KOMP centers in the ES cell era, and; (4) creating cKO alleles for “difficult-to-target”
genes, including those with single exons or unusually long exons, and genes with repetitive sequences, which
together comprise about 15% of all protein coding genes. Having worked on many aspects of mouse genetics;
as a researcher designing and breeding models for my own work, as a transgenic core director advising
hundreds of investigators on the best mouse model options for their research, and as a developer of
breakthrough technologies to move the field forward—my experience helped to identify these key problems in
the field. Using the Genomic Innovator award, I will solve each of these problems by developing innovative
technologies along the lines of Easi-CRISPR. Successful completion of this project will benefit individuals
designing mouse models through their core facilities and will also allow KOMP/IKMC centers to produce the
most generally useful models. Given the very high use of mouse models, developing technologies to address
such universal problems is expected to have a major impact on all fields of biomedical research in the future.

Public health relevance
Project Narrative The CRISPR is a revolutionary genome editing technology discovered in 2013, and our lab developed an improved version of it called Easi-CRISPR, using which complex type of mouse models, that are routinely used in biomedical research, can be developed. Taking Easi-CRISPR to a next level, we propose to develop technologies to solve bigger problems that are universal to all fields of biomedical research including the very lengthy mouse breeding steps generally used in molecular genetics research. The technologies we develop here can offer: new possibilities that were previously not been possible, and; make significant impact to the research communities of all institutes and centers of the NIH